Happiness and Pleasurable Activities as Longitudinal Predictors of Adolescent Alcohol and Cannabis Outcomes

Project Summary/Abstract
Adolescence is the developmental period most strongly associated with the initiation and escalation of
substance use, making it an ideal time to identify protective factors against substance use. Alcohol and
cannabis are among the most used substances in adolescence and their use is associated with negative
consequences. Solidifying emotion regulation strategies and healthful behaviors in adolescence may protect
against later deleterious substance use outcomes. Yet research on the mechanisms underlying substance
use behavior change in adolescents is limited. Consistent with NIDA priorities on prevention targets, there
is a need to focus on the developmental trajectory and elucidation of protective mediators (e.g., happiness,
pleasurable activities) associated with alcohol and cannabis outcomes (e.g., alcohol use, binge drinking,
cannabis use, alcohol-related consequences, cannabis-related consequences) across adolescence. This
study addresses a critical gap in the literature by conducting longitudinal mediation analyses with secondary
data using a large sample of adolescents from the Happiness and Health study (5U54CA180905). This
project is significant in its positive psychological approach of examining positive emotions and pleasurable
experiences rather than solely substance reduction, and in filling a research gap on mediators of substance
use in adolescents. This project is innovative in its integration of the broaden-and-build theory with
behavioral theories of choice by examining how happiness and pleasurable activities are associated. The
broaden-and-build theory posits that experiencing happiness may increase one’s personal resources,
allowing one to come up with a wider range of novel behavioral activities. These expanded behavioral
activities may include novel healthful activities, such as spending time with family or exercising, which are
associated with reduced substance use. Behavioral theories of choice suggest that pleasurable activities
may substitute and protect against substance use and related consequences. The innovative integration of
the broaden-and-build theory and behavioral theories of choice suggests that experiencing happiness may
be associated with improved alcohol and cannabis outcomes through the pathway of pleasurable activities.
The proposed study will examine whether changes in happiness and changes in pleasurable activities are
associated with changes in alcohol and cannabis outcomes (Aim 1), and whether pleasurable activities work
as a mechanism to explain the relationship between changes in happiness and changes in alcohol and
cannabis outcomes (Aim 2). The goal of this proposal is to provide the Applicant with training experiences
that will improve her content area knowledge, analytic skills, grantsmanship and manuscript development,
and network, which are vital to flourishing as an independent researcher. The environment at the University
of Rhode Island, including data analysis software, grant support, and an excellent mentorship team with
expertise in relevant areas, provide the ideal setting for the successful completion of the proposed project.

Public health relevance
Project Narrative Adolescent substance use is associated with numerous negative health consequences, and there are calls to focus on protective factors that may buffer against adolescent substance use and related consequences prior to the development of more severe outcomes in later life. Adolescents are at a critical developmental period for learning and solidifying protective strategies and behaviors against alcohol and cannabis outcomes (e.g., alcohol use, binge drinking, cannabis use, alcohol-related consequences, cannabis-related consequences), yet there is a dearth of research on the protective mechanisms underlying behavior change over time in adolescents. The proposed study will utilize longitudinal mediation to examine if changes in happiness and pleasurable activities are associated with changes in alcohol and cannabis outcomes over time in adolescents; findings will clarify whether happiness and pleasurable activities are promising targets for future research and prevention efforts.